Integrating Responsive Feeding and Nutrition Security to Prevent Early Childhood Obesity in Food-Insecure Populations

Project Summary/Abstract:
Despite an increase in the diversity of the United States (US) population, women from an underrepresented
race/ethnic minority group remain underrepresented in higher education, particularly in the biomedical
research workforce. The University of Nevada, Las Vegas (UNLV) will be the home institution of this diversity
supplement and is a designated Minority Serving Institution (MSI) striving to reduce the barriers that minority
students such as Filipinos have when obtaining higher education. This application aims to build upon the
parent U01 grant to provide mentored research training in community-based participatory research (CBPR)
and mixed-methods research for a pre-doctoral and Filipino woman to promote diversity in the field of early
childhood obesity (ECO) prevention, particularly among food insecure populations. ECO in young children
under the age of three is a public health crisis in the US. The proposed research project builds upon the lessons
learned from the U01 parent grant creating the Early Nurturing Care for Food Security (EARN-FS) multi-level
intervention to promote maternal-child food insecurity to (a) analyze an existing secondary dataset from the
U01 parent grant to assess the risk of nutrition insecurity (i.e., increased consumption of ultra-processed food
and lack of food diversity, including vegetables and fruits) among children who reside in food insecure
households and (b) conduct a scoping review to assess whether and how interventions aiming at food and/or
nutrition security integrate responsive feeding approaches (i.e., child-caregiver interactions during feeding) as
a mechanism to prevent ECO; (c) compile programmatic and policy opportunities within individual, service,
and community-levels to integrate food security, nutrition security, and responsive feeding approaches to
prevent ECO. Through this diversity supplement, the candidate will get direct mentoring from the U01 parent
grant PI and an additional six experts at UNLV to complete five goals: 1) gain mixed-methods research and
advanced CBPR experience, 2) build scientific knowledge on ECO and health disparities, 3) expand her ECO
network and conference presentations, 4) increase her publication record by improving her writing skills, and
5) advance in a PhD in the Public Health program to obtain a terminal degree. The expected outcomes for the
candidate include publishing two peer-reviewed manuscripts as first-author, applying for an NIH F99/K00
Fellowship, expanding her scholarly network, and successfully progressing toward a PhD terminal degree.

Public health relevance
Project Title: Integrating Responsive Feeding and Nutrition Security to Prevent Early Childhood Obesity in Food Insecure Populations. Project Narrative: Despite an increase in the diversity of the United States (US) population, women from an underrepresented race/ethnic minority group remain underrepresented in higher education, particularly in the biomedical research workforce. Childhood obesity has reached epidemic levels, requiring diversifying the workforce who will be researching culturally sensitive approaches to prevent early childhood obesity (ECO) among diverse racial/ethnic and socioeconomic disadvantaged, such as food insecure populations. This diversity supplement application aims to build upon the parent U01 grant to provide mentored research training in community participatory and mixed-methods research for a pre-doctoral and Filipino woman to promote diversity in the field of health disparities in ECO prevention. Letters of Support (Drs. Buccini, Flatt, Sharma, Moonie, Grigsby, Johansen, and Simangan)